Predictive Biosignature for Endoscopic Therapy for Chronic Pancreatitis Pain

Pain occurs in more than 80% of patients with chronic pancreatitis (CP) , which is most commonly caused by
chronic alcohol use. Management of CP pain is challenging, and greater than 50% of patients with CP pain are
placed on chronic opioids, contributing to the opioid epidemic. CP with ductal obstruction can be treated by
endoscopic therapies. However, success rates vary, and despite technically successful procedures, some CP
patients continue to experience pain. The lack of tools for predicting pain treatment response to endoscopic
therapies presents challenges for clinical care, potentially delaying care, leading to more invasive therapies
such as surgery, or unnecessarily exposing patients to opioids. In this proposal we aim to use machine
learning to develop multimodal predictive biosignatures for pain response to endoscopic therapies utilizing
electroencephalography (EEG), quantitative sensory testing (QST), and biopsychosocial variables. Our study
is founded on the premise that while pancreatic pathology initially drives pain, over time alterations in central
pain processing may become a dominant driver of pain in some patients with CP, making them resistant to
therapies aimed at the periphery. Neuroimaging with EEG, sensory testing with QST, and psychosocial
questionnaires assess central vs peripheral changes in pain processing. Combining these tools in a multimodal
biosignature can improve sensitivity and specificity of prediction and advance s election of appropriate
treatment of CP pain. In the UG3 phase of our proposal, we will measure EEG and QST and assess
psychosocial factors in ~100 patients with alcohol-induced CP pain undergoing endoscopic therapy as part of
standard clinical care. Using machine learning algorithms, we will extract features and develop candidate
predictive biosignatures for pain treatment response to endoscopic therapy. In the UH3 phase we will validate
and select the biosignature with the highest area under the curve met ric in a new cohort of patients. Our
success will have direct clinical impact, improving care of this refractory chronic pain syndrome and enabling
similar studies in other chronic abdominal pain syndromes.

Public health relevance
PROJECT NARRATIVE The lack of predictive biomarkers for pain treatment response to chronic pancreatitis (CP) pain hinders clinical decision making, leading to treatment of more than 50% of patients with CP pain with opioids. Our proposal seeks to develop multimodal biosignatures, incorporating electroencephalography, quantitative sensory testing, and biopsychosocial factors, powered by machine learning, to predict pain response to endoscopic therapies for CP pain. Our proposal for development of a predictive biosignature can advance personalized pain medicine and treatment for CP pain, minimizing opioid use.